Redox Cofactor Diversity in Enzymatic Superfamilies

Project Summary
Nature has mastered the ability to use bioavailable metals to achieve spectacular transformations
of chemistry, by combining them with diverse protein folds, and unique coordination
environments. Through the assembly of metalloproteins and metalloenzymes, Nature has
achieved remarkable diversity in chemical transformations and in tuning the nascent properties
of metal ions such as iron, through generating yet-further-modifiable redox-active cofactors, like
iron-sulfur clusters and iron bound in heme cofactors. To achieve that diversity, specific protein
scaffolds and arrangements of iron-sulfur clusters, and/or heme groups have been elaborated
upon extensively, giving us diverse chemistry — much of which, the fields of enzymology and
bioinorganic are still discovering today. Two NIGMS funded research areas ongoing in the Elliott
Group at Boston University are (1) Query the structure-function relationships of the vast, “AdoMet
Radical Enzyme (ARE) superfamily”, where tens of thousands of reactions are thought to be
catalyzed by hundreds of thousands of distinct members of the ARE, through the study of the
redox traits of the iron sulfur clusters found in the ARE superfamily; and (2) Test hypotheses about
structural and chemical diversity found with heme containing enzymes of the so- called “bacterial
cytochrome c peroxidase (bCCP) superfamily” found within gram negative micro-organisms.
Through these two related projects, which form the background of the current R35 proposal, the
diversity of structures, function and redox chemistries of metalloproteins are examined through a
combination of electrochemical, biophysical, bioinformatic, and structural approaches. The
mechanistic details of the ARE superfamily are still forthcoming, where many novel states of iron
sulfur clusters have been proposed; here we will bring our electrochemical lens to bear upon the
nature of those states, in order to understand the thermodynamics and kinetics of their generation
and inter-conversion. With respect to the bCCP superfamily, we have recently demonstrated that
novel forms of reactivity of enzymes of this superfamily can be found by looking beyond the
canonical family members that have been examined for the past 20 years. Here we propose to
examine other new family members that are suggested to engage in sulfur-conversions relevan
to the microbiome and to human health. Together, these studies marry our interests in
bioinformatics and biophysical chemistry, to probe the diversity of nature's redox enzymes,
revealing not only what is possible in the chemistry of these remarkable catalysts, but how nature
masters the desired reactivity with the correct metallocofactor.

Public health relevance
Project Narrative All organisms make use of redox-based processes for energetic transformations that span the fundamental chemistry of living, as well as the protection of the organism from highly reactive radical-based species. Often these transformations are catalyzed by metal-containing cofactors such as iron-sulfur clusters and heme units that are bound within proteins and enzymes. Understanding the diversity of the strategies that nature makes use of in the design and function of such redox-catalysis is critical to understanding the biological chemistry of ourselves and pathogens alike.